Iodine Excess, Thyroid Dysfunction, Cardiovascular Outcomes, and Mortality Among U.S. Veterans

Background and Innovation
The focus of this project is to rigorously add to our understanding of how the use of iodinated contrast media, a
common requirement of many radiologic procedures, is associated with thyroid dysfunction and cardiovascular
risks. In U.S. adults, the recommended dietary allowance (RDA) of iodine is 150 mcg/day. Exposure to
excessive iodine can induce thyroid dysfunction due to two well-established physiologic principles: the failure
to escape from the acute Wolff-Chaikoff effect (resulting in hypothyroidism) and the Jod-Basedow
phenomenon (resulting in hyperthyroidism). The iodine content of radiologic iodinated contrast agents can be
up to several hundred-fold higher than the U.S. RDA for iodine. In susceptible individuals, thyroid dysfunction
(hyperthyroidism or hypothyroidism) can occur even after only a single exposure to an iodine-rich substance.
Thyroid status is important for several cardiac parameters, including systolic contraction, cardiac output,
preload, coronary arteriolar angiogenesis, coronary vascular resistance, vascular tone, and cardiac
hypertrophy.
Significance and Impact to Veterans Healthcare: Iodinated contrast media is commonly required for routine
radiologic and other interventional procedures among patients who receive care from the Veterans Health
Administration. Our published work of the national VHA electronic health records database thus far shows that
iodinated contrast administration is associated with an increased risk of thyroid dysfunction (hypothyroidism
and hyperthyroidism) and of incident long-term adverse cardiovascular outcomes (heart failure and atrial
fibrillation/flutter). This project will build upon our analyses of the existing VHA dataset we have constructed to
robustly refine the understanding of these important associations. The goals of this project will be to: 1) employ
advanced statistical tools to specifically delineate the key factors driving these relationships, and 2) develop a
dynamic relative risk calculator that can be used in real-time to apply the observed associations into routine
clinical practice. This work directly addresses VA/ORD research priorities 2 and 3, to increase the substantial
real-world impact of VA research and put VA data to work for Veterans, respectively.
Path to Translation/Implementation: As use of iodinated contrast in medical settings continues to increase,
the real-world applications of the established risks of iodinated contrast use have not been studied thus far, yet
are urgently needed. The findings of this project, including the creation of a risk stratification tool/calculator,
would directly guide the care of Veterans who commonly receive iodine contrast dye through routine radiologic
studies, such as computed tomography (CT) scans used in anatomical imaging and angiograms required for
cardiac catheterization procedures in centers across the VHA.

Public health relevance
The focus of this project is to add to our understanding of how the use of iodinated contrast media, a common requirement of many radiologic procedures, is associated with thyroid dysfunction and cardiovascular risks. These analyses will build upon our existing U.S. Veterans Health Administration dataset and will: 1) employ advanced statistical tools to specifically delineate the key factors driving these relationships, and 2) result in the development of a dynamic, relative risk calculator that can be used in real-time to apply the observed associations into routine clinical practice. As use of iodinated contrast in medical settings continue to increase, the real-world applications of these established risks have not been studied thus far, yet are urgently needed. This greater understanding would directly guide the care of Veterans who commonly receive iodine contrast dye through routine radiologic studies, such as computed tomography (CT) scans and angiograms used in cardiac catheterization procedures.